Single Cell Molecular Expression

The Single Cell Molecular Expression Core (Core C) provides COBRE/INBRE investigators and other researchers in the Nevada System of High Education (NSHE) with the following services: 1) automated single cell capture followed by cDNA preparation using the Fluidigm C1 Single Cell Auto-Prep system; 2)high throughput quantitative PCR assays and targeted template enrichment using the Fluidigm BioMark HD system; 3) small noncoding RNA deep sequencing (sncRNA-Seq) or targeted DNA deep sequencing using the Ion Torrent PGM sequencer; 4) ribosome profiling to determine translational status of mRNAs in a given tissue/organ using RiboTag mice and RNA-Seq; 5) manipulation of a gene of interest to achieve overexpression, reduced expression, complete inactivation and replacement with another gene using the latest genome editing technologies including ZFNs, TALENs and Cas9-CRISPR in cultured cells. The technologies used in Core C represent the latest technological advancement and were developed in response to the requests from our investigators. In this proposal, we describe in details what services Core C will provide and how Core C will be operated and managed to serve well the needs of our investigators in using these technologies (Aimi), and achieve financial independence during or by the end of Phase III support (Aim2). With the most cutting edge technologies in hand and an executable business plan in place, we are confident that Core C will become part ofthe essential resources to not only our COBRE/INBRE investigators, but also other researchers in UNR or NISHE, and the expanding user base will ensure the ultimate goal of Phase III support, the long-term sustainability. This win-win situation will be accomplished by the end of Phase III funding.

Public health relevance
Core labs equipped with specialized instrumentation and well trained personnel wiil help our biomedical researchers make new discoveries, thus benefiting the public healthcare.